Novel pathways in eicosanoid biosynthesis and metabolism

Abstract
Oxidative transformation of arachidonic acid by cyclooxygenases, lipoxygenases, and cytochromes P450 gives
rise to endogenous lipid mediators that regulate cellular processes in homeostasis and disease. These lipid
mediators form an evolving and expanding family referred to as eicosanoids. This application comprises two
projects that both are concerned with novel transformations in eicosanoid biochemistry and present important
ramifications for the use of non-steroidal anti-inflammatory drugs (NSAIDs) that inhibit their biosynthesis. The
first project is centered around the 5-LOX/COX-2 cross-over biosynthetic pathway while the second project is
concerned with novel metabolic transformations of eicosanoids, and what these mean for the use of plasma
and urinary prostanoid metabolites as markers of drug response. Today, novel members of the eicosanoid
family are often discovered in lipidomics approaches by their similarity with known eicosanoids. We have
employed an approach based on understanding the structure-function of the biosynthetic pathways, enzymes,
and substrates that allowed us to make predictions of novel transformations. This has led to the discovery of
the 5-LOX/COX-2 cross-over biosynthetic pathway forming hemiketal eicosanoids (HKE2 and HKD2) and 5-
hydroxy-prostaglandins, the identification of 15R-prostaglandins formed by aspirin-acetylated COX-2, and the
identification of the Baeyer-Villiger oxidative pathway underlying the metabolism of PGD2 to 11-dehydro-
thromboxanes. Underscoring the relevance of our approach is the fact that the novel eicosanoids we have
shown to be formed in vitro and in vivo have not been identified in lipidomics analyses, likely due to their
unusual properties that make them difficult to detect in standard analyses. We have designed analytical
procedures that allow to detect and quantify the novel eicosanoids in vitro and in vivo. We plan to continue the
identification of novel eicosanoids and to establish their cellular targets and biological role in homeostasis and
in models of inflammatory disease. Our ongoing investigation into the biological effects of the cross-over
eicosanoids has identified the receptor tyrosine kinase (RTK) VEGFR2 as a target for the pro-angiogenic
activity of HKE2, as well as other RTK and an unknown target that mediates inhibition of platelet activation that
are to be further analyzed. For the 5-hydroxy-prostaglandins we plan to employ screening approaches as well
as targeted testing of prostanoid receptors in order to identify their cellular targets and determine biological
effects. We aim to identify compounds that can be used to manipulate biosynthesis of 5-LOX/COX-2 cross-
over eicosanoids independent from the formation of prostaglandins and leukotrienes. We will continue to
characterize novel metabolic pathways of prostanoids and establish the relevance of these pathways in vivo.
Identification and characterization of novel eicosanoids, their biological effects, and novel prostanoid metabolic
pathways will result in a refined understanding of the pathophysiologic conditions for which NSAIDs may be
used and effect of aspirin and other NSAIDs on prostanoid biosynthesis in vivo.

Public health relevance
Narrative Lipids are a source of important messengers that regulate health and disease in the body. Our research is focused on identifying novel lipid messengers and to determine how they exert their messaging capacity and how they are changed by the body. We also want to establish how known medications that are used to treat pain and inflammation interfere with the formation and action of the novel lipid messengers.